Administrative Core [Parent Title: PREVENTING INFANT INFECTIONS WITH IMPLEMENTATION SCIENCE IN MALAWI]

Administrative Core – Summary
The Administrative Core (Admin Core) for this program, “Preventing Infant Infection with Implementation
Science in Malawi” (PRI3SM), will play a central role in achieving our overall objective to identify successful
implementation strategies to eliminate MTCT (EMTCT) in Malawi and beyond. The Admin Core will oversee
the operation, coordination, management, and evaluation of the three projects focused on the EMTCT
cascade. We will join in crosscutting support with the implementation science core and data science and
analytical core to provide advanced support and coordination to each of these study projects. The Admin Core
will support the activities of the projects and cores to enhance the potential for cross protocol comparisons
through harmonized instruments, data systems, and procedures. The Admin Core will also support Ministry of
Health program evaluations and provide mechanisms for engagement of young investigators through existing
capacity building programs.
Through the existing infrastructure of UNC Project Malawi, the Admin Core will assist all core and project
directors with operational and budgetary oversight and management, including submission of progress reports,
communication between EMTCT clinical, research, policy and implementing partners and communication with
NICHD. The core will organize activities that enhance collaborations between both senior and junior
investigators based at UNC-CH, UNC Project Malawi, the Malawi Ministry of Health and PEPFAR
implementing partners. These synergistic and mature relationships have been developed over the past twenty
years of EMTCT activities in Malawi beginning with a collaboration with the Malawi MOH and the Elizabeth
Glaser Pediatric AIDS Foundation (EGPAF) to implement HIVNET012 regimen in 2002; the establishment of
DAIDS network clinical trials including the IMPAACT network; numerous single site research activities through
CDC (the BAN study) and NICHD funding; and an increasing number of implementation science trials0. Most
importantly, policy and practice changes have led to well-established relationships with the Malawi Ministry of
Health and implementing partners. The Admin Core will also assemble and facilitate meetings of both an
External and Internal Advisory Board, and coordinate participation in annual local and global EMTCT meetings.
The Admin Core will ensure that overall goals for the program are accomplished as outlined below.
Aim 1. Enhance the program effort by optimizing communication, decision-making and sharing among the
research project teams, the support cores and the implementing partners.
Aim 2. Develop and maintain shared, dedicated administrative infrastructure to ensure timely and accurate
monitoring, reporting, and regulatory compliance of all EMTCT activities.
Aim 3. Provide administrative support to strengthen existing partnerships in Malawi, between UNC Project,
Malawi Ministry of Health, PEPFAR implementing partners and community partners.